Data Outreach and Promotion

PROJECT SUMMARY (See instructions): The Data Outreach and Promotion Core has three specific aims (1) Develop and implement two competitive small grant programs that will emphasize life course influences on and the intergenerational transmission of health, wealth, and wellbeing; (2) Hold three 2-day conferences where small grant program awardees and other leading scholars, including Program Project Leaders and Investigators, will present their research findings. Two of the conferences will be based on the thematic areas targeted by the small grants programs. A third conference will be held on time use and wellbeing, a topic that cross-cuts each of the other two small grant themes and that will be timed for coordination with the release of time use and wellbeing data. In addition to providing a forum for the exchange of scientific ideas and results, including the presentation of : new research in aging, the conferences will also be used as a mechanism to generate a buzz within the user community by fostering discussion about the new data being collected and scientific and policy questions that the data can address; (3) Develop a series of online, on-demand PSID courses (webinars), an Aging Research Highlight series, and exhibitions at professional conferences to promote awareness of the : aging-related research potential of the PSID. The webinar series will provide step-by-step instruction to users on how to access, download, and analyze the data. By making the series available through the PSID online Data Center, an unlimited number of users will be able to access the courses upon demand. This activity will be supplemented by a new Research Highlights series that summarizes high impact aging related findings with the PSID. We also plan to continue to exhibit and distribute promotional materials at annual social and behavioral professional meetings. Evidence of success in these promotional activities will be gauged a number of ways. We will track data use and webinar/research highlight hit statistics, follow up with grantees and conference participants to learn about the impact of this participation on their scholarship, and track peer-reviewed publications with the PSID considered to be related to aging in general and to the \ thematic topics featured in the conferences in particular

Public health relevance
RELEVANCE (See instructions): The data promotion and outreach activities proposed in Core B will accelerate research progress on aging, life course and intergenerational themes related to health, socioeconomic status, and wellbeing by increasing awareness of the research potential of the Panel Study of Income Dynamics data and providing opportunities for scholarship on such topics.